Transcriptional regulation of mitochondrial metabolism in human intestinal stem cells

PROJECT SUMMARY
Dr. Joseph Burclaff, PhD is mentored by Dr. Scott Magness, PhD at the University of North Carolina at
Chapel Hill. UNC receives the 6th highest federal research funding of any American university and is home to
the NIDDK-sponsored Center for Gastrointestinal Biology and Disease with a vibrant research community. The
CGIBD and Dr. Burclaff’s home department of Biomedical Engineering provide supportive environments for
young investigators. Dr. Burclaff proposes an innovative cross-disciplinary research plan bridging human in vitro
genetic engineering, in vivo mouse work, functional metabolic studies, inflammatory signals, and transcription
factor analysis, all within the frameworks of homeostasis and inflammatory bowel disease (IBD).
Dynamic regulation of mitochondrial metabolism is essential for healthy intestinal stem cell (ISC) activity,
with mitochondrial dysfunction known to drive inflammatory signaling and aberrant cell fates able to initiate
experimental colitis. IBD is marked by decreased mitochondria, increased proinflammatory signaling, and altered
ISC cycling, and mitochondrial and pro-inflammatory signaling are even seen in non-inflamed tissue from IBD
patients, implicating mitochondrial dysfunction as an early event in IBD development or even predisposing the
intestinal epithelium for inflammation. Few transcription factors (TFs) are known to regulate mitochondrial
dynamics in ISCs. My work with primary human ISCs genetically engineered to knockout or induce
overexpression of the TF SOX9 show that SOX9 strongly represses mitochondrial activity, slows cell cycle, and
increases proinflammatory gene expression in ISCs. The specific effects of SOX9 on mitochondria and whether
SOX9 regulates inflammatory signaling and ISC activity directly or by acting through mitochondria are unknown.
This proposal will determine how SOX9 regulates mitochondria and proinflammatory signaling in human ISCs
and in mice. As SOX9 often acts through other TFs, and SOX9 appears to regulate mitochondria without affecting
previously implicated mitochondrial-related TFs in these ISCs, candidate TFs identified using this primary human
intestinal platform will be tested for their ability to regulate mitochondria and ISC activity independently or as a
TF network. Cutting-edge cellular engineering strategies will further test direct downstream targets of these TFs
to determine mechanisms by which this novel network regulates mitochondria in the human intestinal epithelium.
To establish an independent research area in this field, Dr. Burclaff requires mentored time to become
fluent in metabolism and metabolomics, TF interactions with each other and downstream genomic targets, and
IBD development. To achieve this, Dr. Burclaff will be co-mentored by Dr. Costas Lyssiotis at the University of
Michigan, a field expert in metabolism and metabolomic analysis in gastrointestinal tissues and disease states.
Dr. Burclaff also assembled a committee of field experts in metabolism, chromatin and TF analysis, and IBD to
help guide him through this project and in his transition to establish an independent research program to train
the next generation of researchers and to study regulatory mechanisms of ISCs that affect human health.

Public health relevance
PROJECT NARRATIVE The goal of this project is to define novel transcriptional regulators and place them in a hierarchical network that controls mitochondria dynamics and proinflammatory gene expression in human intestinal stem cells. This has significant implications for how the intestinal epithelium may regulate normal turnover and metabolism as well as to identify mechanisms by which disease may develop, as dysfunctional mitochondria are a common early step in diseases such as inflammatory bowel disease. With the high incidence of inflammatory bowel disease and other intestinal diseases across the United States, understanding how major metabolic pathways and inflammatory signals are regulated in the human intestinal epithelium is a pressing public health concern.